CLINICAL EVALUATION OF FORTIFIED FOODS

The objective of this Master Agreement Order is to obtain analytical chemical analysis of selected drug metabolites, arachidonic acid metabolites, and steroid metabolites in human fluids.